A tunable laser scanning system for rapid analysis of biopharmaceutical formulations

Project Summary
The goal of this Direct to Phase II SBIR proposal is continue development of Nirrin’s proprietary tunable
laser spectrometry system in preparation for commercialization. Biomanufacturing at commercial scale requires
precise monitoring of product components, including active pharmaceutical ingredients (APIs) such as proteins,
peptides, and nucleic acids, but also supporting excipients which are essential for overall safety and efficacy.
Process errors can lead to incorrect concentrations of APIs and excipients leading to extremely costly process
revisions and millions of dollars of waste in the form of adulterated product. Ensuring that biomanufacturing
processes remain consistent and compliant with FDA mandates regarding product composition is of urgent
importance to the biopharmaceutical industry. Methods which allow continuous real-time monitoring of product
components and support reliable, accurate and precise measurements are therefore of extremely high value.
Currently manufacturers rely on detailed process documentation to ensure product integrity and protocol
adherence, as well as end-point analysis using HPLC, mass spectrometry, or Raman spectrometry, among other
costly, time-consuming methods. None of these technologies are compatible with rapid, real-time analysis,
supporting only end-point analysis after full commercial-scale batches of product are generated. In fact, many
analytical methods require samples to be sent to contractors with data coming back after multiple days or even
weeks. Nirrin Technologies, Inc. has developed the NXT platform, a rapid and sensitive instrument for the
simultaneous analysis of biopharmaceutical APIs and excipients from a single sample with zero up-front sample
preparation. The system relies on tunable laser spectrometry, scanning samples across multiple wavelengths
and compiling absorbance spectra unique to the given analyte. Absorbance spectra have been developed and
validated for dozens of biopharmaceutical API’s and excipients and can be rapidly analyzed via Nirrin’s
straightforward software user interface. The NXT workflow has been evaluated by multiple biopharmaceutical
companies and satisfies many of the key product requirements which competing technologies do not. During
this Direct to Phase II program, we will optimize the design of the NXT system and fabricate 6 beta systems prior
to internal quality testing. Testing batteries will also be undertaken to satisfy the requirements for global
commercialization, including UL and CE marking. Systems will then be prepared for external validation testing
with at least three major biopharmaceutical companies. These activities are expected to dramatically accelerate
the commercialization of Nirrin’s tunable laser spectroscopy products while reducing manufacturing errors prior
to the launch of new biopharmaceuticals.

Public health relevance
Project Narrative Manufacturing biopharmaceuticals relies on bioprocessing which is comprised of multiple steps including synthesis of components, purification to remove contaminants, and the addition of supporting excipients in very precise concentrations. Ensuring that products are consistent from batch to batch is not only essential to safety and effectiveness but is required by regulatory agencies such as the Food and Drug Administration. Biopharmaceuticals found to be out of compliance can lead to massive costs for manufacturers to dispose of the adulterated product, as well as rebuild bioprocessing practices to eliminate errors in the future. Nirrin has developed the NXT system, a tunable laser spectrometry system which has been evaluated by numerous biopharmaceutical companies for bioprocessing quantitation of APIs and excipients. Here, we will optimize the system, prepare it for commercialization and perform an external validation study, testing the system’s capabilities at multiple biopharmaceutical manufacturers.